AMD Ryan Initiative Study (ARIS)

The ARIS is just being launched. We are currently recruiting the 20 US and international centers for the enrollment of the participants. The contracts and the protocols along with the manuals of operations are currently written. Approvals from the various IRBs are pending. The reading center is almost complete with the certification of the equipment and the personnel for measurement of the functional studies. We have recruited 6 participants at the NEI clinical center. This is a multicenter study which is led by the NIH leadership. This natural history study will hopefully have recruited fully within the next 12 to 18 months.